Short-term research training program for veterinary students

DESCRIPTION (provided by applicant): The objective of this Professional Student Short-Term Research Training Grant is to provide veterinary students who have completed their first or second year with the opportunity to explore research in comparative medicine as a potential career: Students will be engaged in hypothesis-driven discovery and problem-solving research in a high-quality laboratory setting for 12 weeks during the summer. Only the best researchers/mentors from the College of Veterinary Medicine at Michigan State University have been included as trainees in the proposed research training program. Participating faculty have been grouped into 5 areas of research excellence: 1) Comparative Microbial Pathogenesis and Infectious diseases, 2) Epidemiology and Public Health, 3) Comparative Molecular Genetics 4) Comparative Pathobiology, 5) Comparative Toxicology. In addition, an orientation, weekly seminar series, and field trips have been designed to broaden the research experience, as well as to provide students with an understanding of current research issues and career paths in which they can make a contribution to improve public health. Training in responsible conduct of research is an integral part of the program. Recruitment efforts planned are directed not only to DVM students in our college, but to veterinary students from other U.S. colleges of veterinary medicine and are designed to ensure that minority students have access to this research experience. All students participating in the program are required to present their research results at the annual College of Veterinary Medicine Phi Zeta Research Day, and to publish them with their mentors as appropriate. Increasing our human capital in veterinary scientists is critical to the protection of public health and advancement of science that benefits animals and humans, both as individuals and as populations. Summer research experiences provide a critical step into the research enterprise to the veterinary students early in their training and foster interest and develop aptitude for further training in the biomedical sciences. Control and optimal response to diseases such as west-Nile virus and avian influenza that affect both human and animal populations depend on this. In addition, comparative studies in animal models are critical to the understanding of disease processes and of new therapies for human diseases.